A Compact LHe-Free Fast-Switching-Field MRI Magnet for Ratiometric Molecular Imaging and Novel Contrast Exploration

Project Summary
In this project we propose a novel magnetic resonance imaging (MRI) concept based on our innovative fast-
switching-field magnet design. We believe that this MRI magnet will make possible new contrast mechanisms
and ratiometric molecular imaging for biomedical research. We will develop and demonstrate a liquid-helium
(LHe)-free superconducting magnet that can change the field very quickly in time between significantly different
field strengths: a high (3T) field of modest-homogeneity adequate for relaxometry and prepolarization; and a low
(0.5T) field of high-homogeneity for spectroscopy and imaging. New contrast mechanisms enabled by this
magnet include level-crossing between spin 1/2 and quadrupolar nuclei, accelerated spin-lattice relaxation, and
adiabatic demagnetization-remagnetization. By measuring relaxation parameters at different fields, relaxation
contrast sources that have different relative relaxation rates at the fields could be distinguished. This will help
quantify imaging agent concentrations against background or differentiate states of individual agents that exhibit
environmentally-dependent changes in relaxation behavior. The fast field change in a superconducting magnet
can be achieved by adopting most advanced low-AC-loss high-temperature superconductors (HTS) having a
sufficiently high temperature margin to avoid quench. The field switching time between two fields will be rapid
enough (<1 s) to retain polarization and relaxometry yet safe for animal and human. Other applications of our
switching-field magnet might include interventional MR and intraoperative surgery. At 0.5 T susceptibility artifacts
from slightly magnetic devices and implants, and RF heating from conductive devices are much less. We believe
the images can be comparable to 1.5 T with progressing MR spectroscopy and imaging technologies. We are
convinced that our proposed switching-field MR magnet can not only promise novel contrast mechanisms but
also serve as a stepping stone for preclinical animal and even human MRI competitive and cost effective against
conventional MRI magnets. The specific aims are to develop a LHe-free fast-switching-field MRI magnet
prototype by combining two HTS magnets—a 2.5-T switched-field magnet and a 0.5-T MRI magnet—and
demonstrate the MRI field homogeneity and stability during fast field-switching (up to 3 T/s). We will also perform
a conceptual design of a human-size fast-switching-field MRI magnet with optimum design fields. The unique
features of our magnet design are very low-loss and stable in a fast-switching field, impossible with a
conventional low-temperature superconductor (LTS), and configuration of two separately operating HTS
magnets—a steady low field of high-homogeneity and a fast-cycling high field of modest-field-quality—to achieve
fast-switching feature efficiently in performance and cost. Our solid-nitrogen-cooled cryogenic system does not
rely on helium, which has become a scarce and unreliable commodity. Successful completion of this project will
pave the way to larger—including human-scale—and higher field magnets, benefitting biomedical sciences.

Public health relevance
Narrative To advance novel contrast mechanisms in biomedicine and ratiometric molecular imaging applications, we will complete and demonstrate in this 2-year project a compact liquid-helium-free fast-switching-field MRI magnet prototype between 0.5 and 3 T. The enabling, innovative design and operation concepts included in this novel magnet will make practical an expanded array of possibilities for biological and medical MR imaging and spectroscopy that ultimately serve society.